The Third Pittsburgh Rust Belt Microbiome Conference

Project Summary
This application requests partial funding for the Third Pittsburgh Rust Belt Microbiome (RBM) Conference 2024.
Here, we intend to leverage the strength, successes and lessons learned from the conferences held in 2019 and
2022 with an exciting and forward-thinking program featuring a focus on mechanistic studies of the microbiome
through cutting-edge basic and translational research and new developments in the role of the microbiome in
infectious disease, clinical science, and personalized medicine. Our goal is to establish this conference as a
biennial event open to nation-wide attendance yet focused on bringing together the microbiome research and
clinical communities from the “Rust Belt” region including Pittsburgh (University of Pittsburgh, University of
Pittsburgh Medical Center [UPMC], Carnegie Mellon, Duquesne, Allegheny General Hospital, as well as
Allegheny College, Carlow University, and Chatham University) and nearby cities (including Buffalo,
Morgantown, Cleveland, Philadelphia, Cincinnati, and Columbus). The conference will be open to national
attendance, while promoting inclusion of undergraduate and regional institutions and hospital staff who may
otherwise have limited access to national/international conferences on human pathogens and the microbiome.
While research in the microbiome space is presented at other national meetings, the RBM conference
distinguishes itself in multiple ways including research topics focused on new technologies that can be
incorporated into microbiome studies, understanding the challenges and successes of incorporating the
microbiome in translational and clinical settings, and the importance of evolution and adaptation processes in
host-microbiome interactions of adults and infants. Further, the conference emphasizes the integration of basic
and clinical researchers, along with highlighting the work of students and junior investigators. To this end, the
conference will feature several “rapid-fire” sessions for short talks from junior investigators chosen by the
organizing committee from submitted abstracts. There will also be opportunities for students to present their work
in an interactive poster session in which posters are grouped by topics and students orally present posters to
their peers and senior investigators knowledgeable of the subject area. Opportunities for students to interact with
speakers will also be organized. As a part of RBM 2024, we are also growing a workshop (piloted in the 2022
conference) for undergraduates and graduate students on scientific communication to the wider public which will
include the involvement of expert faculty in public communication of science and technology from the University
of Pittsburgh, Carnegie Mellon University and Duquesne University. The conference brings together leading
scientists from multiple disciplines and institutions to advance this vital field while striving for an inclusive meeting
that actively involves and promotes students and junior scientists.

Public health relevance
Project Narrative The Third Pittsburgh Rust Belt Microbiome (RBM) Conference will be open to nation-wide participation while providing a unique opportunity for Rust Belt region scientists, clinicians other healthcare workers to interact in an inclusive, interactive conference environment that will focus on cutting-edge mechanistic and translational research in the role of the microbiome in infectious disease, clinical science and personalized medicine. The conference will also highlight work and professional development opportunities for students and junior researchers in the microbiome space.